Einstein Mount Sinai Diabetes Research Center

The Animal Physiology Core (APC) employs sophisticated research methodologies to assist Einstein-Mount
Sinai Diabetes Research Center (ES-DRC) investigators in the in vivo assessment of glucose and fatty acid
metabolism, insulin sensitivity and energy homeostasis in mice and rats. Through collaborative efforts with the
other Cores of the ES-DRC, the APC enables investigators to thoroughly characterize the effects of defined
pharmacologic, dietary, environmental and genetic alterations on glucose and lipid homeostasis, insulin action,
and metabolism. To accomplish these goals, the Animal Physiology Core will: 1) Offer advice and instruction to
students, postdoctoral fellows, investigators and technical staff in the design and performance of physiologic
approaches and techniques necessary to evaluate the control of glucose homeostasis and insulin action in
rodents, 2) Make available to investigators specialized measurements of whole body and tissue-specific glucose
metabolism and insulin action in rodent models including insulin, pancreatic and hyperglycemic clamps and
spontaneous glucose monitoring, 3) Provide specialized gastrointestinal, neurosurgical and histological models
for the study of insulin sensitivity, energy balance, and glucose and fatty acid metabolism, including gastric
bypass and adipose and hepatic tissue denervation, imaging and photo-stimulation, 4) Provide analysis of whole
body carbohydrate/fatty acid oxidation, energy expenditure, thermogenesis, food intake, and locomotor activity
using specialized metabolic (indirect calorimetry) rodent cages, 5) Provide assessments of the effects of diet,
exercise, light/dark cycle and environmental temperature on continuous and acute assessments of glucose
homeostasis, metabolism, and shivering via electromyography, 6) Make available to investigators specialized
measurements of rodent adipose tissue distribution using magnetic resonance spectroscopy, microCT, as well
as measurements of glycogen in liver and muscle, intrahepatic lipids and intramyocellular lipids using nuclear
magnetic resonance (NMR), 7) Make available to investigators specialized measurements of brain energy and
glucose utilization by functional magnetic resonance imaging (fMRI) and microPET scanning, 8) Assist
investigators in the interpretation of data and to design further experimental approaches to reveal the molecular
and physiological bases of metabolically relevant rodent phenotypes, and 9) Facilitate and integrate the
functional assessments provided by the APC with assays provided by other ES-DRC Biomedical Cores. All these
services are available to investigators new to diabetes research, as well as to investigators working on diabetes-
related projects that can be enriched and extended by the use of the expertise and facilities of this Core.